Core M: Implementation Science

Abstract
Advances in HIV prevention and treatment interventions, together with unprecedented investments to
bring these interventions to scale, presents an opportunity to prevent new infections, avert HIV-related morbidity
and mortality, and dramatically alter the HIV/AIDS epidemic. However, the full potential of recent scientific
advances in HIV treatment and prevention has yet to be realized, and efficacious interventions have not been
adequately scaled into effective programs. Implementation science can improve the uptake and effectiveness of
these programs, and impact health at the population level. Given the imperative to translate evidence-based
interventions into widely implemented programs, implementation science is a scientific priority for the NIH,
domestic and global public health agencies, and UW/Fred Hutch CFAR members.
The UW/Fred Hutch CFAR is ideally situated to link implementation science research with public health
programs both within the U.S., and globally. Our CFAR faculty is at the forefront in defining multidisciplinary,
implementation science research methods, and has developed novel training curricula in public health and
implementation science. Furthermore, CFAR-affiliated investigators lead diverse programs to implement and
scale-up HIV prevention and treatment interventions that have developed strong, collaborative relationships with
health departments throughout the U.S. and internationally.
We propose to establish a new Implementation Science Core to develop implementation science
expertise within the CFAR community, fostering new interdisciplinary implementation science research, and
linking UW’s research and public health activities to promote implementation science in real-world public health
settings. This effort will create new training opportunities for junior researchers, lead to new and innovative
research, and ultimately improve the speed, efficiency, and quality of efforts to translate scientific evidence on
HIV prevention and care into effective, large scale health programs. ISC’s specific aims are: 1) to build HIV
research capacity and foster local, national and international academic-public health collaborations
related to implementation research though short courses, seminars, and online training; and 2) to
increase externally funded, domestic and international implementation science research projects
involving academic institutions and public health agencies. To advance these aims, the ISC will support
trainings and seminars to build investigators’ skills related to implementation science and draw new researchers
into the field; form a mentorship group for junior faculty designed to foster the development of new competitive
research proposals; provide consulting and analytic expertise to CFAR-affiliated researchers on grant
applications and in support of ongoing projects in areas related to implementation science; and create linkages
between CFAR investigators and international and domestic health departments to identify and cultivate
collaborative research.